Sex differences in susceptibility to a PTSD-like phenotype

Experiencing an emotionally traumatic event, even without physical injury, results in developing a debilitating
condition, termed Post-Traumatic Stress Disorder (PTSD) in an estimated 20-30% of people. Women are
affected at twice the rate of men, present with different symptoms and respond differently to the same
therapies that are effective for men. This suggests that PTSD has individual susceptibility and is sexual
dimorphic. Prevalence of PTSD is higher in military personnel leading to rising costs to the Veteran's
Administration and society, in general, due to loss of productivity and quality of life. Since most cases of PTSD
are treatment resistant coupled with a high incidence of people with PTSD who do not seek treatment,
understanding susceptibility is critical to building resilience and helping reduce the incidence of PTSD. We
define susceptibility factors as those that can be identified and manipulated before trauma such that their
manipulation alters the acquisition and/or maintenance of PTSD. With the increase in female soldiers and
Veterans, it is important to investigate if there are sex differences in susceptibility factors to inform if the same
resilience building task will work for both men and women.
We previously developed an animal model for revealing individual susceptibility to a PTSD-like phenotype
before trauma (RISP model). However, we discovered that different parameters are needed to reveal
susceptibility for male and female rats. Exposure to a mild stressor is necessary but not sufficient to reveal
susceptibility in males while in females, the mild stressor is sufficient to reveal susceptibility to developing a
PTSD-like phenotype. Thus, we propose two models: RISP-M for male rats and RISP-F for female rats and
propose to complete the characterization of RISP-F by investigating whether a mild stressor is not only
sufficient but also necessary for revealing susceptibility.
Using RISP-M, we have identified putative susceptibility factors: impaired hippocampal and medial prefrontal
cortex function, and elevated pro-inflammatory cytokines in the medial prefrontal cortex. We also have
evidence that pre trauma interventions that engage the hippocampus and medial prefrontal cortex improved
post trauma outcomes in susceptible male rats. Whether these apply to female rats is currently unknown.
The current proposal builds on our expertise and previous work, supported by the VA. It will test the overarching
hypothesis that susceptibility to a PTSD-like phenotype is sexually dimorphic: it requires different
behavioral determinants, has different susceptibility factors, and can inform sex-dependent resilience-
building interventions with three specific aims: Aim 1: Test the hypothesis that a brief exposure to a mild
stressor (cat hair) is necessary and sufficient to reveal susceptibility to a PTSD-like phenotype in female rats;
Aim 2: Test the hypothesis that putative susceptibility factors for a PTSD-like phenotype are sexually dimorphic;
Aim 3: Test the hypothesis that resilience-building interventions are not sexually dimorphic. The findings will
provide the field with a new model for identifying susceptibility to a PTSD-like phenotype in female rats, begin to
address whether male and female rats have similar susceptibility factors and inform the development of
resilience-building interventions that may need to be different in males and females.

Public health relevance
Post-Traumatic Stress Disorder (PTSD) has caused great suffering for Veterans from loss of productivity and quality of life. It has also placed a significant and increasing financial burden on VHA in disability payments. Considering that PTSD is resistant to treatment, identifying susceptibility factors for PTSD that can be altered to increase resilience, has great potential to both decrease PTSD-associated VA costs as well as decrease loss- of-productivity and increase quality of life for many Veterans. There are sex-differences in susceptibility factors for PTSD. With the increase in female Veterans, it is important to investigate these differences so that strategies to build resilience in each sex can be developed. This grant builds upon findings from an animal model, developed by the PI, to investigate sex-differences in susceptibility factors. We will also investigate resilience building treatments in both sexes.